Long-Acting, Short-Residing Nanochelators for Iron Overload Therapy

Project Summary/Abstract: Iron is an essential metal, but high iron stores are toxic due to increased oxidative
stress produced by iron-catalyzed reactive oxygen species. Increased iron stores are associated with well-
established risk factors of heart and liver failure, arthritis, dyslipidemia, and diabetes, including obesity, metabolic
syndrome, and chronic inflammation, particularly for patients who are genetically susceptible to developing iron
overload. Secondary iron overload occurs in several anemias (e.g., thalassemia, myelodysplastic syndrome,
sickle cell anemia, Diamond-Blackfan anemia) due to repeated transfusions, and increased absorption of iron
loading from repeated transfusions can be major causes of morbidity and mortality in chronic anemia patients.
There are three FDA-approved chelators in the U.S.: deferoxamine (Desferral, Novartis; IV/IM/SC injection),
deferasirox (Jadenu, Exjade; Novartis; oral tablet), and deferiprone (Ferriprox, ApoPharma; oral tablet/solution).
Since 1968, the prototype iron chelator deferoxamine has shown good therapeutic efficacy but requires repeated
injections or continuous infusions, which considerably decreases patient compliance. To overcome this issue,
two oral chelators have become available in the market (deferasirox in 2005 and deferiprone in 2011). Despite
their efficient iron chelation with improved patient compliance, oral chelators have shown significant dose-limiting
adverse effects. For example, deferasirox can cause gastrointestinal bleeding, which may be fatal in elderly
patients, in addition to hepatic and renal toxicities. These adverse effects occur because these small molecule
chelators demonstrate a higher tendency to distribute into non-target tissues, exerting toxicities. Furthermore,
clinicians report that a novel, more convenient, and better-tolerated delivery of the iron chelator would improve
treatment adherence and long-term therapeutic outcomes.
Previously, we have successfully developed a multifunctional nanochelator that captures iron from plasma
and liver, circulates without significant nonspecific uptake in non-target tissues, and leaves the body through
urinary excretion. Armed with this renal clearable nanochelator, we aim to develop subcutaneous injectable
hydrogel formulations with increased exposure for up to 3 weeks and with tracking the release kinetics using
multimodal imaging systems longitudinally. This strategy can decrease the iron burden and reduce the risk of
iron-mediated organ toxicity, with no overt chelator-related adverse effects. Therefore, our hypothesis is that a
thermosensitive injectable hydrogel, which offers a long-term sustained release of iron chelators but a short-term
residence in the major tissues/organs (i.e., rapid clearance upon iron chelation without accumulation), can
improve the therapeutic efficacy of iron chelation while minimizing chelator-induced toxicity, beyond the current
standard treatment of iron overload.

Public health relevance
Project Narrative: High iron stores are toxic due to metal-induced oxidative stress that promotes multiple organ damage, including cardiomyopathy, liver cirrhosis, hypertriglyceridemia, diabetes, and premature death. Using an iron chelator-coated ultrasmall nanochelator that captures iron from the plasma and liver, without distributing it into non-target tissues, we aim to develop subcutaneous injectable hydrogel formulations with increased exposure for 3 weeks. This strategy can decrease body iron burden and reduce the risk of iron-mediated organ toxicity, without overt chelator-related side effects.